Establishment of an International DIPG Registry

Diffuse intrinsic pontine gliomas (DIPG) comprise 70-80% of all brainstem gliomas in children. Approximately 300 children develop brainstem gliomas per year. Prognosis for patientswith DIPGs remains dismal with a median survival of less than 1 year and no improvement in survival has been realized in more than three decades. No effective chemotherapeutic regimens are currentlyavailable.Little is known about the biology of these lesions because they are typically not biopsied and surgical resection is impossible given their location.We are establishing an International Diffuse Intrinsic Pontine Glioma Registry to provide a comprehensive database of clinical, radiologic and pathologic data linked to abioinformatics repository of molecular data of patients. Two initial studies are planned. The website is now available at http://dipgregistry.org/